Next Gen Virotherapy for GBM

Abstract:
The overall goal of this application is to develop a NOTCH blocking strategy in combination with oHSV that can
be safely delivered to intracranial GBM to enhance therapeutic efficacy without neurologic toxicity. In the normal
brain, Notch signaling plays a significant role in memory processing and adult neurogenesis. In glioblastoma
(GBM) NOTCH signaling has also been implicated in the development of resistance to chemotherapy and
radiation, and contributes to the dismal survival associated with GBM, a disease associated with a less than 2
year median survival despite treatment with surgery, radiation, temozolomide, and with tumor treating field
device. The overall goal of this application is to understand the impact of specific NOTCH ligand mediated
NOTCH activation on oHSV therapy for brain tumors. Since NOTCH signaling plays a significant role in the brain
in memory processing and adult neurogenesis, we will also evaluate the impact of blocking specific ligands on
memory development and safety for intracranial usage.
In our preliminary results we have identified that oHSV infection induces NOTCH activation in tumor and tumor
associated macrophages (TAM). NOTCH activation of TAMs results in induction of CCL2 that recruits monocytic
MDSCs to infected tumors. While oHSV treatment awakens anti-tumor efficacy, these monocytic MDSCs limit
the immunotherapeutic benefit by educating an immune-suppressive environment in tumors.
It has been shown that different NOTCH ligands have different effects on anti-tumor immunity. For example,
DLL1-mediated NOTCH activation is important for T cell maturation into memory cells and its overexpression
augments T cell activity and anti-tumor immunity. While JAG1, and to a lesser extent JAG2, induce PD-1 and
suppress T cell immunity. Thus, we hypothesize that blockade of JAG1 mediated signaling should enhance
virotherapy induced anti-tumor immunity, and its transient expression by an oHSV would not create a neurologic
memory deficit in mice. Since, membrane bound ligands can activate NOTCH signaling and soluble monomeric
ligands can inhibit NOTCH signaling, here we will test the effect of blocking individual NOTCH ligand mediated
NOTCH activation on oHSV efficacy and anti-tumor immunity (Aim 1). In aim 2 we will create an oHSV that can
effectively block virus induced ligand specific NOTCH signaling to augment virus induced anti-tumor immunity.
This virus will also be evaluated for safety, sensitivity to ACV, and effect on mouse behavior and memory. Further
we have found that combination of an oHSV with irradiation synergistically activates NOTCH signaling. In aim 3
we will evaluate the effect of this virus in combination with irradiation.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The prognosis for GBM patients remains dismal and there is an urgent unmet need for novel therapies. The first oncolytic virus to be approved by the FDA is an oncolytic HSV whose use is prescribed for melanoma patients. To increase the utility of this novel approach for brain tumor patients we propose to create and optimize a lead HSV derived virus for development for clinical intracranial use without affecting neurologic function.